THALIDOMIDE FOR TREATMENT OF ORAL ESOPHAGEAL APHTHOUS ULCERS IN HIV INFECTION

The purpose of this substudy is to investigate the pharmacokinetics of thalidomide in HIV infected patients with aphthous ulcers.